lncRNA Function and Mechanisms during Cardiac Development and Disease

ABSTRACT
Cardiovascular disease remains the leading cause of death in the United States; however, the genetic causes
and molecular mechanisms underlying these medical conditions have yet to be thoroughly elucidated. As a result,
the identification of new therapeutic targets for the effective treatment of these diseases is urgently required.
Because the majority of the genome is actively transcribed to produce a vast number of non-coding RNA
transcripts, this project is focused on determining the role of long non-coding RNAs in heart disease, which is an
understudied and important area of investigation. Thousands of long non-coding RNAs (lncRNAs), which are
defined as non-coding RNA transcripts greater than 200 nucleotides in length, have been found to have biological
activity in humans and other organisms; they are considered novel regulatory molecules of numerous
physiological and pathological processes, including those in the cardiovascular system. Our earlier RNA-seq
studies identified many differentially expressed lncRNAs in the hearts of patients with ischemic cardiomyopathy.
One of these lncRNAs, known as large intergenic non-coding RNA-p21 (lincRNA-p21), was previously shown to
be a transcriptional target of tumor protein p53 and a novel regulator of cell proliferation and apoptosis. More
recently, it has been implicated in the control of the regulation of vascular remodeling responses in
atherosclerosis. However, the function of lincRNA-p21 in the heart and cardiac disease remains unknown.
We propose to examine the function of lincRNA-p21 in hypertrophic cardiomyopathy and cardiac
regeneration. Our preliminary data using mutant mouse lines demonstrates that lincRNA-p21 is also involved in
cardiac remodeling in response to pathophysiological stress. Therefore, the overall goal of this application is to
clearly define the function and molecular mechanisms of lincRNA-p21 in the heart. We propose to do this by
pursuing the following Specific Aims: 1) to systematically study the in vivo function of lincRNA-p21 in the
heart using gain- and loss-of-function mouse models, 2) to define the molecular mechanisms by which lincRNA-
p21 regulates cardiac remodeling by testing the hypothesis that this lncRNA alters cardiac function by affecting
the expression and function of Kap1/Trim28-dependent genes, and 3) to examine the therapeutic potential of
lincRNA-p21 in treating cardiomyopathy using adeno-associated virus (AAV) vectors to either overexpress, or
AAV/gapmers to knockdown this lncRNA, in mice with cardiomyopathy. As a result, this proposal will
systematically and rigorously assess the role of lincRNA-p21 in heart disease and establish the molecular
mechanisms underlying the function of this intriguing lncRNA. The information obtained from these studies are
anticipated to identify important new molecular targets for the therapeutic treatment of cardiac disease.

Public health relevance
NARRATIVE Our primary research goal is to understand the function of long non-coding RNAs in the cardiovascular system. In this project, we will examine whether the large intergenic non-coding RNA called lincRNAp21 can alleviate pressure overload induced cardiac hypertrophy, a medical condition that is a leading cause of death worldwide and highly relevant to the mission of the NIH. Our studies using mutant mouse models are designed to be translated into novel therapeutic strategies to treat patients with hypertrophic cardiomyopathy.